Essential roles for Pol delta in Pol theta mediated end joining

Project summary (partly from overall specific aims of original proposal)
Polymerase theta (Pol θ, gene name Polq) is essential in cancers deficient in BRCA1/2 – or indeed in cells
deficient in any one of 140 different genes involved in DNA damage responses – yet its deficiency is well
tolerated in most normal cells. As a consequence, targeted inhibition of Pol θ could be effective in as many of
20% of human cancers.
To date, much remains unclear as to how this 290 kDa multi-domain and multi-activity enzyme contributes to
its biological role, and how individual pathway steps are performed. We are addressing this knowledge gap in
Aim 1; investigation of roles for Pol δ is performing pathways steps, which we initiate with the help of this
supplement is essential to achieve this goal. We are additionally investigating the cellular contexts that engage
Pol θ or TMEJ in Aim 2; 3 seeks to integrate insights gained from work performed in support of overall Aims 1
and 2 to develop rationales for safer, more effective therapies.

Public health relevance
Project Narrative (partly from overall specific aims of original proposal) In this proposed supplement to our program project, we will assess possible roles for Pol δ in performing critical steps in a pathway for repair of chromosome breaks; insights from this work will help support other work in this project develop rationales for safer, more effective therapies.